Deciphering fundamental biological processes involving protein-nucleic acid interactions at the molecular level

ABSTRACT
The central goal of the Schumacher lab is to deduce molecular principles governing fundamental biological
processes involving protein-nucleic acid interactions. These investigations focus on processes in microbes and
intersect with the lab’s interests in microbial pathogenesis. Indeed, while the main goal is to elucidate biological
mechanisms at the atomic level, these studies also provide potential targets for the development of urgently
needed antimicrobial agents. Alarmingly, recent estimates suggest that deaths from antimicrobial resistance
bacteria may exceed 10 million deaths worldwide by 2050 if steps are not taken to generate new treatments.
The specific processes we investigate include transcription, DNA organization and RNA editing. Bacteria must
be able to sense and respond to environmental changes for their survival and in some cases, proper
development, so our studies on transcription focus on important networks and address how environmental
cues are signaled and detected by transcription switches. Streptomyces bacteria represent the main source of
antibacterial and other key drugs, which they generate concomitant with development. Thus, understanding
their developmental lifecycle has been of significant interest for decades, although it is a mystery what drives
this process. Our studies in the last few years have revealed that this developmental switch is controlled by the
second messenger, c-di-GMP, functioning through two global transcription regulators, BldD and WhiG. These
regulators control the first and second steps in Streptomyces development, respectively, but how c-di-GMP
levels are sensed and signaled to these regulators are unknown and is a question we will address in this
proposal. Initial studies unveiled a possible link between WhiG and a c-di-GMP phosphodiesterase, possibly
indicating colocalization as a mechanism to control the second developmental step, which we will investigate.
Studies will also be performed to analyze c-di-GMP levels and identify and characterize additional c-di-GMP
modulated developmental regulators. Using a combination of cryo-EM, biochemistry and in vivo studies, we will
also dissect the molecular mechanism by which nitrogen levels are sensed in Gram-positive bacteria by the
novel Glutamine Synthetase-GlnR signaling pathway whereby the central enzyme for a metabolic pathway
(GS) directly transduces nutrient availability to its master transcription regulator (GlnR). Finally, we will
elucidate the signal and mechanism behind the first SOS-independent DNA repair pathway in bacteria.
Another focus of the lab is the unusual RNA editing process in the mitochondria of kinetoplastid parasitic
protozoans called kinetoplastid RNA (kRNA) editing. A recently identified accessory complex, the MRB1
complex, is required for this process. However, the structure and mechanisms of action of this complex are
completely unknown. We will obtain structures of this complex and dissect its various molecular functions in
editing. These combined studies will elucidate fundamental biological processes at the molecular level, leading
to the discovery of potential chemotherapeutic targets against microbial diseases.

Public health relevance
The emergence of multidrug resistant microbes is a serious threat to human health. Delineating the molecular mechanisms behind essential processes unique to microbes presents opportunities for rational design of specific therapeutics to combat this growing concern.